Administrative Core

REVISED SUMMARY – CORE A
The Administrative Core (Core A) is responsible for overall coordination of the PPG. First, Core A will maintain and strengthen the internal structure of the PPG research team. The goal will be to work with PPG investigators to develop priorities and support adherence to these priorities, facilitate planning and implementation of meetings, allow for data transfers, and ensure that members of the team collaborate effectively with others, thus avoiding duplication of effort or poor communication. Second, Core A will ensure that all members of the research team keep up with cross-disciplinary developments and methods, and that they maintain a strategic focus on future research developments. There are continuous ongoing developments in the large number of disciplines that are either central to, or touch on our research; it can be challenging to maintain knowledge in these areas. To respond to this, Core A will continue to host research retreats, which will be attended by both PPG key personnel and non-PPG researchers with innovative work in related areas. Core A will also oversee the continuation of an external scientific advisory board to provide input on the future directions of the PPG, but with new membership, including scientists with expertise in Alzheimer’s disease and related dementias (ADRD). Third, Core A will oversee the wide distribution of research results and will foster connections across institutions and disciplines. The goals will be to disseminate current research through conference presentations and publication in peer- reviewed journals in relevant disciplines, to provide information about the use of claims data to the wider group of healthcare researchers, to continue interactions with authorities and experts on health care policy, to maintain a website for dissemination of Dartmouth data, and to continue the PPG’s support of Dartmouth’s Dataverse website to ensure reproducibility and rigor in research. Finally, Core A will create a platform to consider and approve funding for pilot projects that encourage new and innovative research. This PPG has budgeted funds to encourage pilot studies related to the PPG research agenda.